Adapting and implementing evidence-based breast cancer follow-up in primary care

PROJECT SUMMARY/ABSTRACT
Breast cancer survivors are a growing population and their symptom burden is significant. Despite growing
evidence on specific symptoms and risk management strategies, efforts to translate knowledge into practice
have produced suboptimal results. Primary care is an ideal receptor site for breast cancer survivors, with
studies demonstrating the effectiveness of primary care based survivorship care. Nevertheless, over the past
decade, the emphasis on survivorship care plans and survivorship models has not had an evident impact on
primary care breast cancer survivorship care processes. Over the past two decades, primary care practices
have redesigned structures and care processes to deliver care to different complex populations; however,
breast cancer survivors are not among them. Many currently proposed and tested strategies are considered
oncology-centric and do not fit well within the real world contexts of primary care practices. Results from our
recent research studies indicate that breast cancer survivorship is not considered clinically actionable even
among primary care practices with advanced staffing models. Therefore, capacity building and stakeholder-
informed strategies are needed to enhance the translational potential of survivorship evidence into primary
care practices. This project uses a “designing for dissemination” perspective, blending the implementation
Exploration, Planning, Implementation and Sustainment (EPIS) framework and the primary care Practice
Change Model (PCM) as a theoretical basis for understanding multilevel factors impacting the implementation
of cancer survivorship guidelines in primary care. These perspectives help frame and identify mismatches
among existing policy, practice, provider, and patient motivators to translate the evidence into clinically
actionable primary care practice change strategies. Using a blended implementation/primary care practice
change conceptual framework, this project aims to: (1) engage diverse primary care stakeholders in identifying
actionable, practice-based activities for provision of long-term breast cancer survivorship care in primary care
using depth interviews; (2) prioritize, synthesize, and identify actionable activities for providing care to long-
term cancer survivors in primary care by engaging key stakeholders using modified online Delphi methods and
concept mapping; and (3) implement and evaluate actionable breast cancer survivorship symptom and risk
management activities using a hybrid type 1 effectiveness-implementation cluster study design with waitlist
control in 26 primary care practices. Study results are poised to have profound impact on implementation
strategies used throughout the U.S. to provide long-term care for patients with a history of breast cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE The numbers of breast cancer survivors are increasing and their symptom burden after treatment is significant. Despite a growing evidence base of symptom management and risk reduction strategies, use of these activities in primary care practice remains suboptimal. This study engages critical stakeholders in identifying and prioritizing evidence based activities to enhance breast cancer survivorship care and has potential to impact implementation strategies used throughout the U.S. for long-term care for patients with a history of breast cancer.